A Biosinpired Genetically-Expressible Dual-Modality Peptide-Based Probe for Super-Resolution Correlative Light and Electron Microscopy

1 Abstract
2 The overall goal of this project is to rationally engineer a new genetically expressible lanthanide-based
3 photostable phosphorescent probe with time-integrated single molecule brightness and high electron density
4 for Super Resolution Correlative Light and Electron Microscopy (CLEM) to enable elucidation of cellular and
5 detailed subcellular structures at the pseudoatomic level. Imaging/monitoring single molecules with nanoscale
6 spatiometric resolution within cells is an essential step for investigating the details of cellular processes. Super-
7 resolution and electron microscopy techniques can achieve the resolution required for those purposes and to
8 those ends, fluorescent probes such as fluorescent small molecules, fluorescent proteins (FPs), and quantum
9 dots (QDs) have become essential tools for research and medical diagnostics.
10 Despite the variety of probes that exist, there is an unmet need for a genetically encoded, dual-modality probe
11 suitable for super-resolution Correlated Light and Electron Microscopy (CLEM). Such a probe would have time-
12 integrated single-molecule brightness necessary for super-resolution light microscopy and be electron dense
13 enough to allow visualization/localization by electron microscopy, especially cryogenic electron tomography
14 (CET). To meet those needs, Photon Biosciences is engineering a novel and innovative enabling bioinspired
15 peptide-based probe that has the time-integrated single-molecule brightness and electron density necessary
16 for super-resolution CLEM. The objective of this Phase I project is to rationally engineer a probe to have ≥25
17 Ln3+-phosphorescent centers, which we hypothesize will have the phosphorescence and electron density
18 necessary to surpass current single-modality CLEM probes and then show the probe’s versatility by using it in
19 cryo-luminescence microscopy to guide focused ion beam (FIB) milling of Pseudomonas aeruginosa PAO1
20 expressing a CRISPR-Cas genome-edited engineered construct of our innovative peptide probe fused to the
21 S15 ribosomal protein at native levels as a proof-of-concept for super-resolution CLEM. Aim 1 is to optimize
22 our initial peptide probe via rational engineering for high electron density and brightness. Aim 2 is to develop a
23 multimeric probe from its precursor by concatenation and increase its electron density and brightness further.
24 Aim 3 is to demonstrate proof of concept by cryo-luminescence microscopy. Aim 4 is to demonstrate further
25 proof-of-concept by using the probe for probe-guided FIB milling and tomography. Successful completion of
26 this project will result in an electron dense, time-integrated single molecule brightness, genetically expressible
27 dual modality probe for super-resolution CLEM.

Public health relevance
Project Narrative No dual modality probe of the type that is required for super-resolution correlated light electron microscopy (CLEM) is readily available. To enable elucidation of cellular and detailed subcellular structures at the pseudoatomic level using super-resolution CLEM, Photon Biosciences proposes a novel genetically expressible probe that has high electron density and luminescence necessary to act as a dual-modality probe for both modes of imaging. This novel and innovative probe for super-resolution CLEM will enable biomedical innovations that require modeling regions of interest inside a cell to a pseudoatomic level.